Anti-inflammatory role of MerTK in the RPE independent of diurnal outer segment phagocytosis

Diurnal RPE phagocytosis is an essential aspect of lifelong continuous renewal of photoreceptor outer
segments. Phagocytosis of distal photoreceptor outer segment tips requires activity of RPE surface receptors
of the TAM (Tyro3/Axl/MerTK) receptor tyrosine kinase family. In human patients, mutations
in the mertk
gene
cause an unusually severe form of retinitis pigmentosa with blindness in teenage years. The retina in mice and
rats lacking MerTK develops normally but rapidly degenerates postnatally, with onset of photoreceptor death
before 4 weeks of age. Neuroinflammation and specifically activation and redistribution of retinal microglia has
been reported in adult MerTK-deficient animals and has been assumed to be a consequence of photoreceptor
distress and debris accumulation caused by lack of daily clearance phagocytosis of spent outer segment tips
by the RPE. However, we find that, surprisingly, robust increase in pro-inflammatory cytokines and microglia
activation in MerTK-deficient rat and mouse retina precede postnatal onset of photoreceptor outer segment
renewal and daily RPE phagocytosis. Moreover, our results show that anti-inflammatory treatment is effective
in preventing microglia activation and extending photoreceptor survival and function only if applied at early
postnatal age several days prior to the onset of diurnal outer segment renewal and RPE phagocytosis. In wild-
type retina, MerTK is expressed early postnatally and mainly by the RPE (and not detected in microglia). This
implies that loss of MerTK affects the RPE specifically, directly and before outer segment renewal begins.
Thus, all available evidence supports microglia stimulation by MerTK-deficient RPE independently of RPE
phagocytic activity and outer segment renewal. Here, we propose highly focused, key proof-of-principle pilot
studies to rigorously scrutinize our completely novel concept that lack of MerTK in itself and unrelated to RPE
phagocytosis causes RPE cells to release a pro-inflammatory cytokine, which elicits early onset, harmful
neuroinflammation that in turn accelerates photoreceptor dysfunction and demise. We will test our hypothesis
in 3 independent specific aims. Aim 1 will explore double mutant mice we just generated to test if cytokine is
required for neuroinflammation in mertk-/- retina. Aim 2 will explore if inducing cytokine loss in the RPE alone is
sufficient to eliminate early postnatal harmful neuroinflammation and whether cytokine mediator must be
expressed early postnatally to induce neuroinflammation in mertk-/- retina. Aim 3 will explore polarized,
differentiated RPE cell models (primary, unpassaged wild-type and MerTK-deficient RPE and passage 1
human RPE cells) to determine whether MerTK expression and its kinase signaling activity are directly linked
mechanistically to cytokine transcription, translation, and/or release by RPE cells. Upon completion, this pilot
study will have yielded unambiguous confirmation or disproof of our novel hypothesis and generated in vivo
and culture models for large scope mechanistic and pre-translational follow-up.

Public health relevance
Mutations in the mertk gene cause severe forms of retinitis pigmentosa in human patients that are characterized by early onset and for which no cure or therapy exist to date. Thus far, studies investigating retinal disease due to MerTK deficiency have centered on MerTK’s function as phagocytosis receptor. In this pilot proposal we will test the novel hypothesis that lack of MerTK receptors directly and independently of RPE phagocytosis stimulates release of pro- inflammatory mediators by the RPE, which in turn elicit harmful neuroinflammation.